Cortactin Binding Partners in HNSCC Phenotypes

DESCRIPTION (provided by applicant): Abstract: Head and neck squamous cell carcinoma (HNSCC) is the sixth most common cancer type in the world, and there has been only a limited increase in survival rate over the last 30 years unlike the significant survival improvements in better-studied cancer types such as breast and prostate. Although molecular alterations are overall poorly characterized in HNSCC, the actin-binding protein cortactin has been shown to be overexpressed in 30-40% of HNSCC, due to the presence of its gene (CTTN) in the 11q13 amplicon. Importantly, numerous studies have shown that cortactin overexpression at the protein, mRNA and genomic DNA levels is highly correlated with poor prognosis. Cortactin was originally identified as a src kinase substrate, and has been shown to be important in actin cytoskeleton rearrangement, migration, and invasion. Our laboratory has shown cortactin to be important for various cancer-associated phenotypes in HNSCC, including tumor growth and invasion, serum- and anchorage-independent growth, migration and invadopodia formation. Our recent data suggest that underlying mechanisms for these phenotypes include alterations in membrane trafficking, with consequent regulation in secretion of proteinases and other autocrine secreted factors. Cortactin binds to a number of proteins necessary for cancer progression, including Src kinase and filamentous actin (F-actin). However, the molecular mechanisms and cortactin-binding proteins that are important for these functions of cortactin have yet to be elucidated. To determine the molecular interactions of cortactin that are important in promoting tumor aggression, I propose two specific aims: 1, to determine which cortactin binding interactions are critical for cortactin-dependent HNSCC cell phenotypes in vitro and in vivo; and 2, to test the role of cortactin binding partners in cortactin-sensitive cellular phenotypes. By investigating these aims, I hope to identify new potential therapeutic targets for treatment of HNSCC.

Public health relevance
PUBLIC HEALTH RELEVANCE: The actin binding gene cortactin is overexpressed in 30-40% of head and neck squamous cell carcinoma, and generally correlates with poor prognosis and more aggressive cases. However, the molecular mechanisms by which cortactin promotes aggressiveness are poorly understood. This proposal seeks to elucidate which cortactin binding partners and domains are critical for tumor cell phenotypes. Narrative The actin binding gene cortactin is overexpressed in 30-40% of head and neck squamous cell carcinoma, and generally correlates with poor prognosis and more aggressive cases. However, the molecular mechanisms by which cortactin promotes aggressiveness are poorly understood. This proposal seeks to elucidate which cortactin binding partners and domains are critical for tumor cell phenotypes. __SpecificAimsTextDelimiter__ A. Specific Aims Head and neck squamous cell carcinoma (HNSCC) is the sixth most common cancer type in the world, and there has been only a limited increase in survival rate over the last 30 years unlike the significant survival improvements in better-studied cancer types such as breast and prostate. Although molecular alterations are overall poorly characterized in HNSCC, the actin-binding protein cortactin has been shown to be overexpressed in 30-40% of HNSCC, due to the presence of its gene (CTTN) in the 11q13 amplicon. Importantly, numerous studies have shown that cortactin overexpression at the protein, mRNA and genomic DNA levels is highly correlated with poor prognosis [1]. Based on the importance of cortactin in HNSCC, the long-term goals of this grant are to elucidate the molecular mechanisms through which cortactin promotes HNSCC progression and to identify new therapeutic targets for treatment of HNSCC. Cortactin was originally identified as a src kinase substrate, and has been shown to be important in actin cytoskeleton rearrangement, migration, and invasion. Our laboratory has shown cortactin to be important for various cancer-associated phenotypes in HNSCC, including tumor growth and invasion, serum- and anchorage-independent growth, migration and invadopodia formation. Our recent data suggest that underlying mechanisms for these phenotypes include alterations in membrane trafficking, with consequent regulation in secretion of proteinases and other autocrine secreted factors. Cortactin binds to a number of proteins necessary for cancer progression, including Src kinase and filamentous actin (F-actin). However, the molecular mechanisms and cortactin-binding proteins that are important for these functions of cortactin have yet to be elucidated. The specific goal of this grant is to understand the underlying cellular and molecular mechanism(s) for cortactin-mediated tumor aggressiveness in vivo. Based on previous data, I hypothesize that cortactin regulates tumor aggressiveness phenotypes by multiple binding interactions, including through proteins that bind to the SH3 domain. To address this hypothesis, I propose the following two Specific Aims: Specific Aim 1: Determine which cortactin binding interactions are critical for cortactin-dependent HNSCC cell phenotypes in vitro and in vivo. Cortactin alters various cellular phenotypes through binding to additional molecules. To determine which binding interactions are critical for specific phenotypes, I will use human HNSCC cell lines in which cortactin has been stably knocked down with shRNA; I will then re-express specific cortactin mutants in which the residues on cortactin that are important for the binding of known cortactin-interacting proteins have been altered. The goal of this aim will be to link cortactin binding interactions to specific phenotypes by observing which mutants are able (or unable) to rescue cortactin- sensitive phenotypes. For example, it is likely that the Arp2/3 binding domain will be required for many phenotypes; however, as we have previously shown for migration, the SH3 domain may not be required for all phenotypes. Specifically, I will examine these cell lines for rescue of cortactin-sensitive cellular phenotypes, including serum- and anchorage-independent growth, changes in Golgi morphology, the formation of invadopodia, and matrix metalloproteinase (MMP) secretion. In addition, I will connect specific in vitro phenotypes to in vivo tumor growth and invasion, using a semi-orthotopic HNSCC xenograft model used previously in the laboratory. Through these studies, I will elucidate the molecular mechanisms underlying cortactin-associated HNSCC tumor aggressiveness and link in vivo tissue to in vitro cellular phenotypes. Specific Aim 2- Test the role of proteins that bind to cortactin's SH3 domain in cortactin-sensitive cellular phenotypes. Several binding partners have been shown to bind to the SH3 domain of cortactin, including Neural Wiskott-Aldrich Syndrome protein (N-WASp), WASp-interacting protein (WIP), FGD1, Dynamin, ZO-1, Shank, CD2-associated protein (CD2AP), cortactin binding protein 90 (CPB90), and EC myosin light chain kinase (MLCK). However, the functional significance of these protein-protein interactions in the context of HNSCC remains unclear. N-WASp, dynamin2, and SHANK2 are likely to work with cortactin to promote cellular phenotypes such as tumor aggressiveness: SHANK2 is amplified along with cortactin in the 11q13 amplicon, and N-WASp and dynamin2 are critical for the formation of invadopodia, a cancer cell- associated structure. Therefore, I will test whether these 3 cortactin binding partners specifically affect HNSCC cellular phenotypes associated with cortactin-induced aggressiveness. Experimentally, I will use knockdown and overexpression studies in HNSCC cell lines to determine whether each of these proteins affects a subset or all of the cellular phenotypes associated with cortactin overexpression. Based on relevance to cancer, I will start with serum- and anchorage-independence, as well as secretion of matrix metalloproteinases. These experiments will test the importance of cortactin-binding proteins in cancer cell phenotypes and identify potential additional therapeutic targets.